The influence of air pollution on lung health among people living with HIV.

SUMMARY/ABSTRACT
Significance: Chronic obstructive pulmonary disease (COPD) is a leading cause of global mortality, and women
are at particular risk. Women who smoke have higher COPD risk, faster disease progression, and rising mortality
rates compared to men who smoke, even at similar levels of tobacco exposure. Among those who have never
smoked, COPD is more prevalent among women. HIV is an important non-tobacco related driver of COPD risk,
and over half the global population with HIV are women and girls, but how HIV-associated COPD risk differs
among women is unknown. Mechanisms driving the accentuated COPD risk among women are an area of active
investigation, but changes in sex hormones during the menopausal transition may play a key mechanistic role.
Women with HIV may have more advanced reproductive aging than women without HIV, which may further
compound the COPD risk in this vulnerable population. Women have historically been underrepresented in
COPD studies and studies of HIV-associated lung disease, so a deeper understanding of the influence of
reproductive aging on lung health among women is essential to ensure the most comprehensive care of women
aging with HIV. Our overarching objective is to characterize reproductive aging and its associated effects on lung
health among HIV+ and HIV- women in Uganda. Innovation: Distinct advantages include: 1) A strategic focus
on women in a resource-limited setting, where most global COPD mortality occurs and most women living with
HIV reside, and thus our study cohort is representative of the environmental, occupational, and infectious
exposures for most women affected by the confluence of the COPD and HIV epidemics, 2) Leveraging a well-
characterized cohort in a global setting with 7 years of lung function and stored blood samples, allowing us to
conduct advanced statistical analyses characterizing complex relationships, and 3) A novel biomarker-based
approach to defining reproductive aging that prospectively identifies women approaching menopause.
Investigators: Dr. Markella Zanni, an endocrinologist with expertise in hormonal mechanisms of non-
communicable comorbidities among people with HIV, joins my mentorship team to guide aspects related to
reproductive aging. Approach: We will leverage 7 years of stored blood samples to characterize reproductive
aging among 126 women with and without HIV in the parent K23 cohort and pair these data with historic lung
function data to test the following Specific Aims: 1) Using previously-collected demographic and health history
data, I will identify predictors of advanced reproductive aging; and 2) Using historic lung function data, I will
determine whether advanced reproductive aging modifies or mediates the relationship between HIV and lung
function decline. Impact: These data will complement my K23-funded work by providing a deeper
characterization of HIV and lung health among women, will inform future R01 proposals designed to test
interventions to mitigate menopause-related lung dysfunction, and will establish a biorepository of reproductive
aging data that can be used to study the influence of sex/gender on other health outcomes in sub-Saharan Africa.

Public health relevance
PROJECT NARRATIVE Advanced reproductive aging and the associated sex hormone changes are an important but understudied driver of COPD risk among women, for whom COPD mortality continues to rise while mortality among men declines. Recent evidence suggests that the 20 million women living with HIV globally – already at risk of HIV-associated COPD – may have more advanced reproductive aging than women without HIV, which may further compound their COPD risk, but women are underrepresented in research cohorts of HIV and lung disease. This project characterizes reproductive aging among 126 women with and without HIV in Uganda, and evaluate the influence of reproductive aging on the relationship between HIV serostatus and lung function, which will establish a biorepository of reproductive aging data, inform future R01-level studies designed to characterize lung health across the reproductive lifespan, and create collaborative opportunities to study the influence of sex/gender on other communicable and non-communicable health outcomes in sub-Saharan Africa.